Apolipoprotein conformation in amyloid and cardiovascular diseases

Abstract
Aberrant lipoprotein metabolism is a hallmark of obesity that affects >40% of Americans. Obesity and its com-
plications, including type-2 diabetes (T2D), cardiovascular, amyloid and severe viral diseases, are the leading
causes of premature death. The ultimate goal of this research is to help diagnose and treat these disorders. This
project addresses critical unresolved questions in the lipoprotein functionality in obesity. High-, low- and very low-
density lipoproteins (HDL, LDL and VLDL) are diverse nanoparticles comprised of lipids and apolipoproteins that
direct lipid metabolism in plasma. This process is extremely complex and many details are unknown. Our current
focus is on the interactions of lipoproteins and proteins with heparan sulfate (HS), which can trigger both cardio-
vascular and amyloid diseases. We will determine the molecular mechanisms of apolipoprotein-HS interactions
and altered lipoprotein functionality in obesity. Our powerful approach, which integrates a wide array of biochem-
ical, biophysical and computational tools, enabled us to postulate compelling new hypotheses that will be tested
in three complementary specific aims. Aim 1 will determine how lipoprotein functionality changes in obesity be-
fore and after treatment. Lipoproteins from healthy and morbidly obese subjects will be isolated based on the
heparin binding affinity, and their biochemical and functional properties will be determined. Our new hypothesis
supported by strong pilot studies will be tested: small particles formed upon action of lipoprotein lipase on circu-
lating VLDL provide novel biomarkers of obesity and readouts for treatment. Aim 2 will define the biochemical
and functional details of serum amyloid A (SAA) transfer from HDL to LDL in obesity. Our pilot studies indicate
that transfer of this small protein induces pro-atherogenic changes in LDL, and suggest two hypotheses that will
be tested: i) new mechanistic links between obesity, elevated SAA and atherosclerosis, and ii) novel beneficial
role of SAA as a lipid scavenger in obesity. Aim 3 will determine how HS and heparin affect SAA misfolding in
amyloid A (AA) amyloidosis, a life-threatening complication of obesity and chronic inflammation. SAA binding to
HS is a therapeutic target in AA amyloidosis but molecular details are lacking. Our pilot studies suggest that: i)
SAA binding to HS initiates an extracellular pathway of amyloid deposition; ii) periodic anionic arrays in HS bind
to stacks of basic residues in amyloid and stabilize amyloid nuclei. To test these intriguing new ideas, we will
combine biochemical, biophysical, hydrogen-deuterium exchange mass spectrometry, and computational meth-
ods with atomic structures of SAA in crystals and fibrils. Outcome: this research will identify new mechanistic
links between obesity and atherosclerosis; verify the hypothetical vital role of SAA as a lipid scavenger; clarify
its misfolding pathway in amyloid; and help develop new diagnostic tools and treatments for obesity and related
disorders. Broader impact of this research is that it will: i) help understand and modulate the causal link between
obesity, T2D and severe COVID-19 disease, and ii) uncover the molecular underpinnings of HS-amyloid inter-
actions that can critically impact not only in AA but also Alzheimer's and other major amyloid diseases.

Public health relevance
Public Health Narrative This fundamental research will determine how “good” and “bad cholesterol” and associated proteins change their functionality in obesity. This research will also determine how these proteins interact with heparin, and how these interactions can contribute to the life-threatening complications of obesity such as cardiovascular and amyloid diseases.